IN VIVO REGULATION OF REGIONAL LIPOLYSIS BY THE SYMPATHETIC NERVOUS SYSTEM

Sympathetic nervous system activity in abdominal adipose tissue will be measured using a tracer for the determination of regional norepinephrine kinetics.